Role of the lncRNA BORG in Breast Cancer Metastatic Progression and Recurrence

Although metastasis is the most lethal characteristic of breast cancer (BC), our understanding of the
molecular mechanisms that govern this event remains incomplete. Interestingly, many BCs disseminate long
before their primary tumors become symptomatic. In fact, ~50% of women diagnosed with small tumors of the
breast (4 mm) already harbor disseminated carcinoma cells in their bone marrow. Moreover, these
micrometastases escape clinical detection by remaining latent for years before reemerging as incurable
secondary tumors that are insensitive to chemotherapies that were originally effective against the primary tumor.
A major barrier to eradicating BC reflects the paucity of knowledge related to how mammary tumors acquire
metastatic and recurrent phenotypes, which underlies the inability of science and medicine to detect and treat
latent micrometastases. These knowledge deficits are especially problematic for triple-negative breast cancers
(TNBCs), which are highly aggressive and prone to rapid relapse; they also lack FDA-approved targeted
therapies necessary to improve their dismal overall survival rates. Long noncoding RNAs (lncRNAs) have
recently emerged as powerful global regulators of chromatin remodeling and gene expression in diverse
physiological settings, including cell and tissue homeostasis, embryogenesis and development. Moreover, an
ever expanding array of scientific evidence related to the pathophysiology of lncRNAs in human disease led us
to postulate that developing and progressing TNBCs hijack the global chromatin reprogramming ability of
lncRNAs, thereby eliciting emergence from metastatic latency and initiating lethal disease recurrence.
Accordingly, we identified BORG (BMP/OP-Responsive Gene (BORG), as a powerful oncogenic lncRNA whose
aberrant expression correlated with the acquisition of EMT (epithelial-mesenchymal transition) and metastatic
phenotypes in (a) human and murine TNBCs cells; (b) human breast tumors and their corresponding CNS
metastases; and (c) patient-derived xenograft (PDX) models of human BC as compared to normal breast
epithelial cells. Additionally, BORG is sufficient in driving latent disseminated TNBCs cells to reactivate
proliferative programs both in vitro and in vivo, events associated with epigenomic reprogramming operant in
repressing cellular senescence programs, and in activating cell survival programs. Based on these and other
preliminary findings, we hypothesize that BORG drives TNBC metastasis and recurrence by (i) remodeling the
epigenome to reactivate proliferative programs that circumvent quiescence- and senescence-associated
transcriptomes, and (ii) promoting the induction of survival signaling systems coupled to the acquisition of
chemoresistant phenotypes. These hypotheses will be addressed by two Specific Aims. Aim 1 will determine
the mechanisms whereby BORG:TRIM28 complexes form and drive TNBC metastasis and recurrence. We will
identify the minimal BORG determinants necessary to bind TRIM28, as well as the domains in TRIM28 that bind
BORG. Additionally, we will map the chromatin alterations provoked by BORG by performing TRIM28 and
H3K4me1 ChIP-seq analyses in BORG-proficient and -deficient TNBCs, findings that will be validated in human
breast cancer specimens. Aim 2 will determine the mechanisms whereby BORG:RPA1 complexes and NF-kB
promote TNBC survival and chemoresistance. Similar to Aim 1, we will identify the minimal BORG sequences
necessary to bind RPA1, and conversely, the regions in RPA1 that interact with BORG. The impact of preventing
BORG:RPA1 complex formation on TNBC survival and chemoresistance will be determined, as will the role of
ATM in regulating the interplay between TRIM28 and RPA1 when bound to BORG. Finally, the impact of these
events in mediating TNBC resistance to cytotoxic chemotherapy will be assessed in vitro, and in preclinical
therapy trials. Collectively, the findings obtained in this innovative application will provide novel molecular insights
into how BORG drives TNBC to acquire metastatic, recurrent, and chemoresistant phenotypes.

Public health relevance
Metastatic breast cancer (BC) is the 2nd leading cause of death in woman in the United States. Generally speaking, metastasis is incurable and results in a median survival of only 1.5 to 3 years for patients with metastatic disease. In fact, treatment goals for women with metastatic disease no longer aim to produce a cure, but instead focus on symptom management and prolonging the length and quality of life for these patients. A major barrier to eradicating BC reflects the paucity of knowledge related to how metastatic latency is initiated, maintained, and overcome, and to how these metastatic “time bombs” can be defused in BC patients. Information derived from our highly innovative and medically relevant studies will (i) provide valuable information on how disseminated BC cells undergo and eventually emerge from latency, as well as on how the novel long noncoding RNA, BORG, drives the long-term survival and reactivation of proliferation programs in metastatic BC cells; and (ii) map the epigenomic landscape and its reprogramming as disseminated BC cells escape from metastatic latency and recur in response to aberrant BORG expression. Importantly, our findings will significantly impact the diagnosis and eventual treatment of metastatic BCs, thereby improving the clinical outcome for patients bearing this deadly disease.